An integrated multiplexed diagnostic assay targeting fusion lipoproteins and cardiolipin for detection of treponemal and nontreponemal antibodies in syphilis patients

Abstract
Syphilis cases in the US are increasing at an alarming rate and the need for a rapid diagnostic test that can
quickly inform treatment and management decisions is desperately needed. An accurate diagnosis of syphilis
relies on recognizing a constellation of symptoms, reviewing medical and sexual history, and performing multiple
laboratory tests. The mainstay of routine laboratory diagnosis of active syphilis infection remains serological
detection of treponemal and nontreponemal antibodies. Detection of treponemal-specific antibodies is evidence
of infection, however, it may indicate past, successfully treated infections since these antibodies persist for
decades. Non-treponemal serological response to cardiolipins is suggestive of potential syphilis infection but is
not sufficiently specific to support treatment decisions. Further, responses to non-treponemal antigens are
generally titered in the laboratory to allow clinicians to assess increases or decreases in titer that support clinical
decision making regarding the stage of the disease. There are only two FDA-cleared syphilis rapid tests that
would support immediate decision making. However, both are of limited clinical utility because they detect only
treponemal-specific antibodies. Currently, there is no point-of-care device available in the US that can test for
active syphilis infection, which requires the addition of non-treponemal antibody testing, preferably with a semi-
quantitative result. This is necessary to determine appropriate treatment with high sensitivity and low false
positive rate. Innovations in this area have yet to be translated into clinical practice. Combining treponemal and
nontreponemal assays within the same platform will provide a more definitive, stand-alone diagnosis of syphilis.
The proposed rapid assay will fill this gap by utilizing ultra-sensitive electrochemical detection of resistance
potential changes that results from the direct interaction of nontreponemal and treponemal antibodies against
lipoidal material and T. pallidum antigens respectively. By using 2D nanomaterials (e.g., graphene), which have
been successfully used in the development of assays for other pathogens, this electrochemical test can detect
subtle interactions between the sensing platform and the targeted analytes. We proposed to use modified
cardiolipin for the detection of nontreponemal antibodies and antigens from T. pallidum for the detection of
treponemal antibodies. If the target antigen-antibody complex is present, graphene's carrier mobility will change,
resulting in a change in electrochemical signal. The proposed electrochemical platform demonstrated ultra-
sensitivity of 1 fg/mL for treponemal antibodies, and opened avenues for fast, accurate detection of
nontreponemal sera. This project aims to develop a sensing platform that allows simultaneous detection and
semi-quantification of treponemal and nontreponemal antibodies that can identify and differentiate active from
past cases of syphilis within 10 minutes.

Public health relevance
Project Narrative Currently available rapid syphilis tests have limited utility as they only detect treponemal-specific antibodies and do not detect or titer non-treponemal antibody responses which is critical information necessary to clinical decision making. Thus, there is currently no point-of-care device available that can diagnose active syphilis infections and assess prognoses with high sensitivity and low false positive rates. We propose a novel application of a biosensor platform that will result in a rapid test that simultaneously detects non-treponemal (semi- quantitatively) and treponemal antibodies, which is desperately needed to fill the current gap in the syphilis case- finding and management toolkit.